CHEMOTHERAPY VS AUTOLOGOUS BONE MARROW TRANSPLANT FOR HIGH RISK NEUROBLASTOMA

The purpose of this investigation is to determine which of two treatment programs, intensive chemotherapy followed by consolidation chemotherapy or intensive chemotherapy followed by bone marrow transplantation, provides a better outcome for children with high risk neuroblastoma diagnosed after one year of age. Each regimen will include randomization to a 6 month maintenance phase of biotherapy with cis-retinoic acid or no further therapy.